Exploring Daily-Level Associations Between Protective Behavioral Strategies, Alcohol Use, and Consequences: The Role of Context and Social Determinants of Health within Adolescents and Young Adults

PROJECT SUMMARY/ABSTRACT
It is essential to examine risk and protective factors for alcohol use due to the high prevalence and associated
negative consequences among adolescents and young adults. Despite protective behavioral strategies (PBS)
being a central part of alcohol prevention programs, PBS could be used with higher frequency, thus research is
needed to determine factors related with PBS use and its association with alcohol related outcomes.
Therefore, Aim 1 will investigate how the PBS subscales (i.e., limiting/stopping, manner of drinking, serious
harm reduction) relate to alcohol use (i.e., number of drinks) and negative consequences (i.e., any
consequences, quantity of consequences) at the daily level. Research further indicates that contextual factors
may influence PBS use; however, it is unclear which contexts are influential at the daily level. Hence, Aim 2
will examine how contextual factors (i.e., drinking games and pregaming) moderate the associations between
daily-level PBS use and alcohol use/negative consequences. Moreover, previous research has specified that
facets of social determinants of health (SDOH) are associated with alcohol use; however, there is a lack in
understanding how they may serve as potential risk or protective factors within PBS. Thus, Aim 3 will explore
how SDOH (i.e., socioeconomic disadvantage, race, ethnicity, sex) moderate the associations between daily-
level PBS use and alcohol use/negative consequences. This research will provide the first ecologically valid,
daily-level examination of the associations between PBS use, alcohol use, negative consequences and the
moderating effects of contextual factors and SDOH. This study will use data from a parent R01 that utilized an
ecological momentary assessment (EMA) burst design consisting of 24 daily surveys over the span of 3-weeks
that repeated four times. Findings may identify novel targets for more efficacious interventions to decrease
alcohol use or increase PBS use. The overall goal of this application is to support and facilitate the necessary
training to develop an independent research career focused on examining contributing factors to adolescent
and young adult alcohol use. In the long-term, the applicant seeks to become an expert research scientist on
the etiology and the risk and protective factors that contribute to alcohol use among adolescents and young
adults. Through the training goals, guided mentorship, and complementary experiences, the proposed project
will strategically advance the applicant’s knowledge of adolescents and young adults and their alcohol use
research. The applicant will also be trained in daily-level ecological momentary assessment (EMA)
methodologies to enhance our current understanding of factors influencing daily alcohol use behaviors and
related outcomes within adolescents and young adults.

Public health relevance
PROJECT NARRATIVE Adolescent and young adult alcohol use is a significant public health concern. The proposed research will advance the field by contributing to our understanding of the role of protective behavioral strategy use in the etiology and prevention of alcohol use and co-occurring negative consequences. Findings fit within the NIAAA’s strategic plan by providing information that may lead to the development or substantial improvement of interventions that aim to decrease or prevent alcohol misuse through targeting influential factors (i.e., drinking games, pregaming) as well as address the health disparities that may impact alcohol use and negative consequences at the daily-level via social determinants of health (i.e., race, ethnicity, sex, socioeconomic disadvantage).